Path B Produce Safety Cooperative Agreement Program 2021-2026

PROJECT SUMMARY ABSTRACT
Project Title: The FDA’s Cooperative Agreement Program for States and Territories to
Implement a National Produce Safety Program
Funding Opportunity Announcement (FOA) Number: PAR-21-174 - Path B
Jul 1, 2021 – Jun 30, 2026
Project Background: Outbreaks of illness caused by consumption of fruits and vegetables
(produce) contaminated with disease-causing microorganisms have a measurable and
important negative effect on public health in the US, due to costs of medical treatment, loss of
productivity, and, in too many instances, mortality. The FDA has promulgated a Produce
Safety Rule intended to foster the implementation of preventive measures that reduce the
likelihood of microbial contamination throughout the produce industry. Broad compliance
with this rule will require education, outreach, technical assistance, inspection, and
enforcement activities beyond the scope of existing FDA programs. State food safety regulatory
agencies can assist the FDA in this public health initiative by leveraging existing programmatic
resources to create state-run produce safety regulatory programs. The Wisconsin Department of
Agriculture, Trade and Consumer Protection (DATCP) has worked to implement the Produce
Safety Regulatory Program (PSRP) in Wisconsin for the past five (5) years and desires to
continue.
Project Goals: The goal of this project, DATCP’s Produce Safety Regulatory Program (PSRP), is
to expand DATCP’s capacity to educate and promote further implementation of the Produce
Safety Rule to diverse members of the Wisconsin agricultural community. Project personnel
will: 1) continue to perform a jurisdictional self-assessment to determine available and needed
resources, 2) develop a dynamic inventory of produce farms in Wisconsin that are subject to the
Produce Safety Rule, 3) continue to improve and create educational, outreach, and technical
assistance programs to guide grower compliance, and 4) develop the infrastructure, along with
inspection and compliance procedures, necessary to implement a fair, effective, efficient, and
sustainable produce safety regulatory program.

Public health relevance
Project Narrative The Wisconsin Department of Agriculture, Trade and Consumer Protection’s project entitled “The FDA’s Cooperative Agreement Program for States and Territories to Implement a National Produce Safety Program” is intended to continue implementation of a Produce Safety Regulatory Program that encourages the production of safe fresh fruits and vegetables and compliance with the requirements of FDA’s regulation “Standards for the Growing, Harvesting, Packing, and Holding of Produce for Human Consumption” (commonly referred to as the Produce Safety Rule). Improving produce safety will protect public health by reducing the incidence of foodborne illness resulting from the consumption of produce contaminated with disease-causing microorganisms. The expected outcome of this work is a highly integrated Wisconsin Produce Safety Regulatory Program that educates produce businesses in best practices for minimizing the contamination of fresh fruits and vegetables with pathogenic microorganisms, and verifies that these practices are followed. Funding Opportunity Announcement (FOA) Number: PAR-21-174 - Path B Jul 1, 2021 – Jun 30, 2026